Dynamics Of Excitatory Synaptic Transmission In The CNS

The brain stores information in patterns of synaptic connections within large networks of neurons. New information is incorporated into a neural network through the modification of connections via mechanisms that are incompletely understood. One fundamental question is whether individual connections behave independently, or whether they are influenced by the activity of neighboring synapses. Synaptic connections are made through the release of diffusible neurotransmitter molecules that bind to receptors on the recipient neuron; recent evidence suggests that the neurotransmitter may escape the synapse in which it is released and diffuse into neighboring synapses. This "spillover" of neurotransmitter between synaptic connections would have a profound impact on the information capacity of neural networks and the mechanisms by which they are constructed during development. Work in this laboratory is directed towards determining whether the excitatory neurotransmitter glutamate spills over between synapses in the hippocampus, a major site of learning and memory storage in the brain, and in the retina, where visual stimuli is encoded for transmission along the optic nerve. Using electrophysiological techniques in acutely prepared slices of rat retina and hippocampus, we have found that glutamate escapes the synapse from which it is released and diffuses into neighboring synapses. This diffusion is tightly regulated by glutamate transporters, pump proteins located primarily on glial membranes that bind glutamate and remove it from the cerebrospinal fluid. Moreover, it appears that the electrical state of the recipient neuron influence whether the receptors are responsive to low levels of glutamate released from a distant synapse. Work is continuing to investigate the modulation of these mechanisms and their impact on information processing in networks of neurons. In addition, we are recording transporter-mediated synaptic responses in hippocampal astrocytes in an effort to estimate more quantitatively how fast synaptically released glutamate is cleared from the extracellular space. Glutamate appears to be taken up with 3 milliseconds following release, suggesting that it is able to diffuse 1-2 microns from its point of release. Other work in the hippocampus indicates that glutamate transporters on inhibitory synaptic terminals provide substrate for synthesis of the inhibitory transmitter GABA. This suggests a novel mechanism by which excitotoxic effects of increased extracellular glutamate levels may be offset by locally enhanced inhibition. This may be particularly important during epileptic siezure activity. Our work in the retina indicates that certain types of receptors may be localized specifically to limit their activation under certain conditions. On ganglion cells, NMDA-type glutamate receptors appear to be located perisynaptically, such that their activation is prevented by glutamate transporters unless many vesicles of glutamate are released simultaneously. More recent work in the lab indicates that these perisynaptic receptors may extend the range over which ganglion cells respond to light stimulation. Other experiments in which we record simultaneously from synaptically coupled retinal neurons indicate that ribbon synapses are capable of very fast transmitter release, even though their physiological release is slow. In addition, our experiments indicate that ribbon synapses coordinate the simultaneous release of multiple vesicles during evoked responses. These results may provide new insights into the function of the synaptic ribbon. Other work in the retina explores the inhbitiory, GABAergic feedback from A17 amacrine cells onto rod bipolar cells. This feedback appears to be mediated by a complex combination of GABA-A and GABA-C receptor-mediated components.